Novel Glycogen Synthase Kinase-3 (GSK-3) Inhibitors as Therapeutic Agents

PROJECT SUMMARY/ABSTRACT
Glycogen synthase kinase-3 (GSK-3) is a highly active kinase that has been implicated in a variety of pathologies
including neurodegenerative diseases, metabolic disorders, cancer, and conditions involving a dysfunctional
innate immune response. Thus, there is an ongoing, intense effort aimed at developing inhibitors of GSK-3.
Despite these endeavors, no specific GSK-3 inhibitor is currently on the market. There remains, therefore, a
critical need for the development of new GSK-3-specific compounds that would be effective at treating diseases
caused by aberrant GSK-3 activity.
Our long-term research goal is to discover and develop safe, and cost effective, GSK-3-specific inhibitors that
can be used as therapeutic agents in the treatment of human disease. We have identified a novel small organic
compound, COB-187, that exhibits potent and selective inhibition of GSK-3. Our central hypothesis is that the
class of compounds exemplified by COB-187, termed I-GSK-3s, represent a novel chemical scaffold upon which
highly potent and selective GSK-3 inhibitors can be designed.
We will complete the following specific aims that will elucidate the mechanism of action of the I-GSK-3s and
probe their potential as therapeutics for pathologies involving dysfunctional cytokine expression. First, COB-187
consists of a thiazolidine-2-thione ring that has a hydroxyl and phenyl group attached to one of the ring carbons.
We suspect that these groups are key to imparting COB-187’s potency and selectivity. Thus, in the first aim we
will determine the importance of the ring-appended phenyl and hydroxyl groups to COB-187’s inhibitory activity.
The results of these studies will be incorporated into our ongoing work aimed at refining the chemical definition
of I-GSK-3s. Second, aberrant cytokine expression in response to foreign- or self-antigens underlies a host of
pathological conditions. Specifically, the dysfunctional induction of CXCL10 through mechanisms involving 2’3’
cyclic GMP-AMP (cGAMP) is key to multiple disorders and is an attractive therapeutic target. Several studies
suggest the involvement of GSK-3 in this pathway. Thus, in the second aim we will probe the hypothesis that I-
GSK-3s inhibit, via suppression of GSK-3 activity, cGAMP-induced CXCL10 production.
Compounds represented by this novel chemical scaffold have the potential to become therapeutics for disease
processes involving aberrant GSK-3 activity. The proposed work will provide a strong scientific foundation for
the development of such therapeutics. Thus, successful completion of these studies will have a positive impact
on a host of human pathologies including conditions involving dysfunctional cytokine expression.

Public health relevance
PROJECT NARRATIVE The aberrant activity of glycogen synthase kinase 3 (GSK-3) has been implicated in an array of pathological conditions including sepsis, diabetes, cancer, and Alzheimer’s disease. Thus, agents that inhibit GSK-3 activity could become powerful therapeutics for a host of diseases. We have identified a set of novel small organic compounds that appear to be potent and highly selective inhibitors of glycogen synthase kinase 3 (GSK-3). In this project, we will address key issues that directly relate to the therapeutic potential of these compounds.